Discovery and development of OGG1 activators as precision drugs for modification of Alzheimer's disease progression.

PROJECT SUMMARY
Alzheimer’s disease (AD) is a leading cause of dementia with 1 in 85 adults affected worldwide. The lack of
disease-modifying therapies or mechanistic biomarkers to reliably monitor treatment are key unmet needs.
Current standard of care (SoC), i.e., acetylcholinesterase or NMDA receptor blockade, provides limited
symptom-relief. Current evidence indicates that an inter-related, mechanistic triad is formed in AD by oxidative
stress (OxS), mitochondrial (mt) dysfunction and inflammation. This pathological trio occurs early and is
fundamental to AD. OxS primarily arises from unproductive mt-respiration and promotes mt-dysfunction.
Oxidized guanine (8-oxo-dG) is the most prominent oxidative and mutagenic DNA lesion, particularly in mtDNA.
Excessive amounts signify insufficient repair. Improving mt-function by enhancing mtDNA repair will modify AD
progression. Repair of 8-oxo-dG is an indispensable, mitochondrial quality control mechanism that largely occurs
by base excision repair. Accumulation of 8-oxo-dG leads to double-stranded breaks which cause mtDNA
deletions and fragmentation and culminates in loss of bioenergetic capacity and cell viability, a prominent AD
pathological feature. Fragmented mtDNA is expulsed to stimulate multiple proinflammatory pathways. Although
there are mt-approaches with potential for AD treatment, there are presently no therapies that target base
excision repair of oxidative damage. Luciole Pharmaceuticals’ approach is to improve DNA repair using small
molecules to enhance the catalytic activity of the DNA glycosylase, OGG1. In the first step of base excision
repair, OGG1 excises 8-oxo-dG while recruiting other pathway enzymes to complete repair in the nucleus and
mitochondria. Increasing OGG1 activity will result in the efficient removal of 8-oxo-dG to prevent strand breaks.
Ultimately, energetics and inflammation will improve to preserve neuronal function and slow AD progression.
Recent publications using either physio- or pharmacological approaches in AD murine models support our
hypothesis. Building on our previous success in discovering novel OGG1 activators (OAAs), we will develop
“first-in-class” orally available, small molecule OAAs that are differentiated from AD SoC drugs to modify AD and
advance patient quality of life in a multi-billion-dollar market. In this Phase I SBIR project, we plan to progress
OAA chemistry and in vitro screening assays to improve OAA potency and in vivo efficacy. If successful, our
Phase II project will include; 1) advancing a lead to candidate selection, 2) testing optimized compounds for
mtDNA expulsion in challenged human-derived iPSCs and murine AD models, 3) early safety assessment and
4) generating a novel mutant mouse model for testing the candidate compound.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is a very serious, incurable disease of the brain, which is a common cause of death throughout the world. By targeting a novel therapeutic target, Luciole Pharmaceuticals is developing first-in-class agents as disease-modifying therapeutics for AD. Our efforts have the potential to lead to the discovery of a novel, safe, and very effective oral medicine for AD, which will improve patients’ quality-of-life and increase their life expectancy.